Toward a Validated in Vivo Imaging Marker of Axonal Damage Predictive of Progressive Disability in Multiple Sclerosis

SUMMARY
Axonal damage occurs early in multiple sclerosis and is considered the pathologic substrate of progressive
disability. The spatiotemporal dynamics of axonal loss in relation to acute and chronic demyelination are not well
characterized and likely vary between patients, lesion types, and within the normal-appearing white matter
(NAWM). With the emergence of promising therapies targeting remyelination, noninvasive imaging markers with
greater specificity to axonal pathology are needed to improve our understanding of disease progression in MS.
Histopathological analyses of MS tissue have confirmed significant reductions in axon density within lesions and
NAWM accompanied by a range of morphological alterations in axonal structure, including the appearance of
ovoids, swelling, thinning, and transection. We have demonstrated the imaging correlates of axonal swelling and
loss in the corpus callosum of MS patients using high-gradient diffusion MRI, leveraging the 300 mT/m gradient
strengths on the Connectome scanner for the in vivo microscopic assessment of axonal structure.
Our goal is to validate these cross-sectional imaging findings through longitudinal investigation and
systematic comparison against histopathology to gain a better understanding of the spatial and temporal
evolution of axonal degeneration in MS and the pathogenic factors influencing disease progression. We
hypothesize that chronic demyelination leads to axonal swelling and eventual dropout that can be detected as
increased axonal size and decreased density by high-gradient diffusion MRI, and that the degree of axonal
morphologic change throughout the brain reflects progressive axonal dysfunction and manifests as progressive
clinical disability. We will pursue a longitudinal imaging study to determine the relationship between
demyelination and progressive axonal structural pathology in MS lesions and NAWM throughout the whole brain.
We will evaluate the relative influence of demyelination and axonal damage on the development of progressive
physical disability and cognitive dysfunction in MS. In collaboration with investigators at the Cleveland Clinic, we
will calibrate and refine diffusion MRI measures of axon diameter and density in MS lesions and NAWM against
axon diameter and density measurements from histopathology in postmortem MS brain tissue.
The prevalence of axonal loss in postmortem samples, and the absence of a reliable biomarker for axonal
loss in living patients, reinforces the need for a validated imaging correlate of axonal degeneration that would
allow us to track changes in axonal structure in real time rather than at their end stage on autopsy specimens.
High-gradient dMRI techniques that map axon diameter distributions in MS patients will enable us to corroborate
the changes in axon diameter observed on pathology. The data generated from this study will advance our
understanding of the role of axonal damage in the pathogensis of MS and facilitate the development of clinically
usable in vivo imaging markers of axonal structural pathology to aid in patient selection and assessment of
treatment response in trials of neuroprotective therapies in MS.

Public health relevance
PROJECT NARRATIVE A major barrier to the development of effective treatment options for multiple sclerosis include is the limited specificity of clinical imaging markers for axonal damage, one of the key contributors to disability progression. This project will evaluate the relative influence of demyelination and axonal damage in the development of permanent disability in MS by providing a validated noninvasive MR imaging marker of axonal damage using strong imaging gradients. The tool will be validated through longitudinal and imaging-histopathologic studies and form the basis for identifying clinically relevant imaging outcomes in assessing response to reparative and neuroprotective therapies in MS.